Role of GPNMB Signaling in Remyelination by Oligodendrocyte Progenitor Cells

ABSTRACT
Loss of oligodendrocytes gives rise to demyelination, ultimately resulting in axonal degeneration and debilitating
clinical outcomes in diseases like Multiple Sclerosis. While remyelination can prevent neurodegeneration, there
are currently no approved therapies for promoting remyelination. Thus, there is an urgent need to identify factors
that control remyelination. Oligodendrocyte progenitor cells (OPCs) in the adult brain are one of the key sources
of remyelinating oligodendrocytes. However in chronic demyelination, they are inefficient for remyelination due
to depletion and/or a block in their maturation. Using a combination of bioinformatic analysis and remyelination
studies in mice, we discovered a novel mediator of the 7*)? pathway, Gpnmb which is highly expressed along
with its receptor CD44 in response to demyelination. Gpnmb is a transmembrane protein that is cleaved by
proteases into an intracellular domain (Gpnmb-ICD) and an ectodomain (Gpnmb-ECD). While Gpnmb-ICD can
signal intrinsically by translocating to the nucleus, the released Gpnmb-ECD functions as an autocrine or
paracrine signal by interacting with CD44 receptor in the same cell or a neighboring cell respectively. In the first
aim, we will define the cell-autonomous function of Gpnmb in oligodendrocyte progenitor cells and in the second
aim, we will determine the combined effect of intrinsic and extrinsic Gpnmb signaling on OPCs following
cuprizone induced demyelination. Together, these studies will not only help elucidate the molecular mechanisms
involved in maturation of adult OPCs but may also identify therapeutic targets for promoting remyelination.

Public health relevance
PROJECT NARRATIVE Lack of remyelination results in axonal degeneration and debilitating clinical outcomes in demyelinating diseases like Multiple Sclerosis. Here, we propose to determine how TGF[31 signaling regulates remyelination through Gpnmb, a novel modulator of the pathway, expressed highly in response to demyelination in oligodendrocyte progenitor cells. These studies will help to determine new strategies for promoting remyelination in the diseased human brain.